Building a next-generation AMP-AIM Data Management Core to maximize FAIR-ness of autoimmune and immune-mediated disease research resources

PROJECT SUMMARY/ABSTRACT
The Accelerating Medicines Partnership Autoimmune and Immune-Mediated Diseases (AMP-AIM) program is
developing a diverse array of multi-omic and imaging data to study multiple diseases, including rheumatoid
arthritis, systemic lupus erythematosus, psoriasis, psoriatic arthritis, and Sjögren's disease, with an overarching
goal to identify common inflammatory pathways and unique molecular underpinnings to these diseases. This
proposal is designed to extend the work of the Accelerating Medicines Partnership Alzheimer's Disease (AMP-
AD) Data Coordination Center (AD-DCC) grant (U24AG061340) to support the coordination and dissemination
of resources of the AMP-AIM program. Specifically, this work aims to expand the access to and enable reuse of
resources being developed in the AMP-AIM program by using the systems, processes, and technology
developed in the AMP-AD program to both increase within consortia sharing and broader sharing with the
research community.
Due to similarity in data structure being between collected in the Accelerating Medicines Partnership Rheumatoid
Arthritis and Systemic Lupus Erythematosus (AMP-RA/SLE) program and the structure of data currently being
hosted through the AMP-AD program, a supplement mechanism was used to provide rapid support of AMP-
RA/SLE (U24AG061340-03S3). A second supplement project (U24AG061340-04S2) built on work done in the
initial funding period to support the management of existing AMP-RA/SLE Phase I and Phase II resources by
enabling upload of new Phase II data, expanding on features of the Autoimmune and Related Knowledge Portal
(ARK Portal), and positioning the ARK Portal to accommodate requirements from the AMP-AIM program.
This proposal aims to establish what we view as a “next-generation” AMP-AIM Data Management Core (DMC)
to maximize FAIR-ness of autoimmune and immune-mediated disease research resources. We intend to achieve
this vision by (1) evolving the AMP-AIM data sharing infrastructure while providing continued data management
support to establish a standards-driven research ecosystem; and (2) enhancing ARK Portal resource
dissemination to enable standards-powered discovery and reuse.

Public health relevance
NARRATIVE The Accelerating Medicines Partnership Autoimmune and Immune Mediated-Diseases (AMP-AIM) program extends single-cell, disease deconstruction approaches—previously employed to investigate rheumatoid arthritis and systemic lupus erythematosus—to additional autoimmune diseases. AMP-AIM investigators and cores are generating rich and varied high-dimensional, multi-omic data across diseases, tissues, and relevant clinical states. The proposed AMP-AIM Data Management Core will provide standards-driven infrastructure and expert support to facilitate sharing of research resources that are maximally findable, accessible, interoperable, and reusable.